Cognitive strategy training in Post-COVID-19 Syndrome: A feasibility trial.

Project Summary/Abstract
The long-term goal of this project is to help improve recovery from cognitive impairment associated with post-
COVID-19 syndrome (PCS). PCS cognitive symptoms require the rehabilitation community to investigate ways
to: (1) reduce the functional impact of the symptoms on daily life and (2) support individuals with PCS to
establish new habits to improve and maintain health. The research hypothesis is that an activity-based
metacognitive-strategy training intervention, the Cognitive Orientation to daily Occupational Performance (CO-
OP) approach can feasibly be administered remotely and will improve activity performance, cognitive function,
and quality of life in individuals with PCS. The specific aims of this study are to assess the: (1) feasibility of
delivering CO-OP remotely to individuals with PCS in preparation for a future R01 trial; and (2) effect of CO-OP
on activity performance, subjective and objective cognitive function, and quality of life in a sample of individuals
with PCS as compared to an inactive control group. Specific aims will be completed through a single-blind,
parallel, exploratory, randomized controlled trial. Individuals with PCS will be identified and asked to complete
a prescreening survey to evaluate eligibility. Those meeting eligibility will undergo a baseline assessment
battery. Participants (n=65) will then be randomized to a remote CO-OP treatment group (45 minutes per week
for 10 weeks) or to an inactive control group. A post-intervention assessment will be completed immediately
following the intervention. The purpose of this R21 is to evaluate feasibility outcomes and to obtain estimates
of effect and precision of response on the outcome measures. To explore the effects of dosage on the primary
outcome of activity performance, the biweekly COPM ratings will be plotted against time. Independent samples
t-test and chi square test will be used to investigate differences among the two study arms and to assess
whether randomization was successful. Descriptive statistics will be calculated for demographic information
and the measures of intervention acceptability. Pre-to-post change in each of the outcome measures will be
calculated for both groups. Cohen’s d effect size reported with precision around the estimate, 95% confidence
intervals, will be used to evaluate the within and between group effects of the interventions on the primary and
secondary outcome measures. The expected outcomes of this study are: (1) data to support the feasibility of
remotely administering CO-OP; and (2) data to estimate effect sizes and precision of estimates of the CO-OP
intervention in PCS. These data will be important for planning a future clinical trial to confirm any effects. This
proposal is timely and consistent with the research priority of the National Center for Medical Rehabilitation
Research (NCMRR) to identify, prevent, and treat key secondary conditions (e.g. PCS); the research program
area of chronic symptom management; and the NICHD Notice of Special Interest (NOT-HD-20-03) addressing
rehabilitation needs of COVID-19 survivors.

Public health relevance
Project Narrative A large portion of individuals infected with COVID-19 experience long-term adverse symptomatology (i.e. post- COVID-19 syndrome (PCS), including “brain fog,” that negatively affects their return to everyday life activities, such as working, driving, and financial management. Rehabilitation interventions are urgently needed to address cognitive impairments experienced following COVID-19 and to reduce their functional impact. This study will evaluate if a metacognitive-strategy training intervention, the Cognitive Orientation to daily Occupational Performance (CO-OP) approach, can feasibly be administered remotely and will improve activity performance, subjective and objective cognition, and quality of life in individuals with PCS experiencing cognitive symptoms as compared to an inactive control group.